The Role of the Vocal Ligament in Vocalization

PROJECT SUMMARY/ABSTRACT
This research addresses an important public health concern, the development and maintenance
of adequate pitch variation and vocal clarity throughout the life span. Evidence has been
growing that vocal pitch range and stability of vocalization can be maintained with voice training
and therapy techniques that rely heavily on repeated pitch glides, presumably to stretch the
vocal ligament. It is impossible to measure directly the time-course of remodeling the vocal
ligament with exercise in live humans. However, strong inferences can be drawn from structural
and mechanical diversity across several species, from tissue engineering, and from
computational modeling. In this proposal, we combine (1) microscopic imaging to test collagen
density and fiber orientation in multiple species, (2) bioreactor design of a vocal ligament with
combined axial and vibrational stress and selected growth factors, (3) finite-element computer
modeling to predict fundamental frequency ranges and stability in vocal fold adduction, and (4)
human subject exercise protocols to increase fundamental frequency range and vocal adduction
control. While the aims can all be executed independently, they cross-validate each other on the
basic premise that the vocal ligament is critical for fo range and can change over time. A first
hypothesis is that the ligament can sustain high tension (up to 1 MPa) for high fundamental
frequencies. A second hypothesis is that the vocal ligament serves as a stabilizer in vocal fold
posturing and maintaining a consistently straight fold edge for glottal closure. Doses of repeated
stretching are designed for engineering tissue in vitro and for human subject exercises. Results
will benefit a large population of people who are vocally active but whose voices appear
physiologically weak or aged.

Public health relevance
PROJECT NARRATIVE A crucial component of healthy and expressive vocalization is a fundamental frequency (pitch) range that can provide ample prosody in speech and melodic range in singing. Humans and non-human mammals and birds exhibit considerable variety in vocal fold design to accommodate pitch ranges necessary for survival and social interactions. Here we explore the properties of the vocal ligament, a layer of vocal fold tissue often referred to as the vocal ”cord”, which we will show to be responsible for an extended pitch range and stability in vocalization.